Assessing the Impact of Flavor Restrictions on Smoking and Vaping

PROJECT 3 Abstract
In the US, at least six states and hundreds of localities have restricted or banned sales of flavored electronic nicotine
delivery systems (ENDS) in order to reduce youth vaping. Yet the evidence on these policies’ effects on individual
behavior is mixed, and some studies link the policies to increases in combustible cigarette use (“smoking”). Nationally
generalizable estimates for such regulations’ effects on contemporaneous cigarette, cigar, and ENDS use—the three
most popular tobacco/nicotine products in the US—are needed to clarify the policies’ immediate impacts and model longer
run effects on these behaviors as well as related health outcomes and health disparities. Thus, focusing on the Behavior
and Impact Analysis scientific domains described in RFA-OD-22-004, we will apply quasi-experimental research
designs—methods designed to produce causal estimates in the absence of randomized assignment—to nationally
representative, restricted-use survey data on adults and adolescents as well as retail sales data, in order to clarify such
flavor restrictions’ effects. Matching these datasets to data on state and local ENDS flavor restrictions, Aim 1 will estimate
ENDS flavor restrictions’ effects on youth and adult smoking and vaping, with sensitivity checks testing whether effect
estimates vary with policy attributes (e.g., retailer exemptions). To consider differential effects by urban-rural status and
other demographics, Aim 2 will then test whether responses to flavor restrictions vary across urban vs. rural jurisdictions;
assess the extent to which this might be explained by geographic factors (e.g., proximity to jurisdictions that allow flavored
ENDS sales) vs. differences in resident characteristics; and estimate implications for both urban-rural and demographic
attributes in smoking and vaping. As a federal flavor restriction’s impacts may differ across areas with distinct state and
local tobacco control policies, Aim 3 will assess how flavor restrictions’ effects differ between localities with more vs. less
restrictive tobacco control policy environments. Those results will be used to estimate implications for the effectiveness of
a federal flavor ban, given observed variation in local policies. Finally, to further aid the Food and Drug Administration in
evaluating new policies’ effects, Aim 4 will use retail sales data to provide rapid analyses of the association of new federal
flavor regulations’ to tobacco/nicotine product sales (e.g., banning sales of menthol cigarettes or non-tobacco flavored
cigars) and consider associations of regulations with the sales of newer non-nicotine flavoring products intended for use
with cigarette, cigar, and/or ENDS, and thereby better understand how their availability modifies flavor laws’ effects. Thus,
this research will clarify flavor restrictions’ effects on youth and adult rates of cigarette, cigar, and ENDS use, providing
key parameters to inform our Center’s modeling of flavor restrictions’ long-term public health impacts, and thereby aid
CTP in assessing the impact of FDA flavor policies.